Regulation Of Suppressor T Cells by PTEN

[unreadable] DESCRIPTION (provided by applicant): [unreadable] It is increasingly clear that the maintenance of tolerance to organ and tissue allografts requires the participation of regulatory/suppressor T cells (Tregs). While several types of Tregs exist in mice and man, the best characterized set are CD4+CD25+ Tregs, which are essential for homeostasis of the immune system. One of the most striking features of CD4+CD25+ Tregs is that unlike effector CD4+ T cells, CD4+CD25+ T regs fail to proliferate in response to IL-2 stimulation alone, although they express all 3 chains of the IL-2R. Recently, we have begun to study this feature of Tregs, reasoning that this unique regulatory control of downstream IL-2R signals would be important for understanding ontogeny and growth/expansion requirements of T regs as a prelude to their development as therapeutic tools in transplantation. Our data show that CD4+CD25+ T regs are responsive to IL-2 by: (1) undergoing blast transformation without cell division; and (2) acquiring resistance to apoptosis with induction of Bcl-xL protein. Detailed biochemical studies of IL-2R signal transduction in CD4+CD25+ T regs demonstrate intact and normal phosphorylation of STAT-5 but absence of phosphorylation of the PI-3K targets Akt or p70S6 kinase. Surprisingly, we find that PI-3K itself is activated by IL-2, suggesting downstream regulation of PI-3K targets in Tregs. Additional data demonstrate that Tregs constitutively express high levels of the lipid phosphatase PTEN, a regulation of PI-3K signal transduction, and that TCR stimulation of Tregs, which is known to induce IL-2 responsiveness, completely blocks PTEN expression in association and newly enables IL-2 mediated PI-3K downstream signaling. These data show that IL-2R signaling in T regs is distinctly different from that of "normal" T effector cells, and strongly implicates PTEN as an integral part of that process. Based on these data we have three aims: In aim #1, we will determine the kinetics of PTEN downregulation following TCR activation. Pharmacologic inhibitors as well as mice and cell lines with defects in TCR signaling will next be used to determine the signaling mechanisms which regulate this process. In aim #2 we will use mice with partial and complete deficiencies of PTEN in T cells, as well as with inducible deficiencies, to determine the role of PTEN in regulatory cell development and in vitro function, in particular on IL-2 requirements and responsiveness. Finally, in aim #3, we will employ transplantation models to study the in vivo role of PTEN in Treg biology. Collectively, we believe these studies will define an important paradigm in the biology of CD4+CD25+ T regs, provide information important for their development as therapeutics, and have broader implications in the field of PI-3K coupled signaling, which is a key controller of T cell responses. [unreadable] [unreadable]